eMERGE Phase IV Clinical Center at Mass General Brigham

Abstract: To improve health equity in implementation of Genome Informed Risk Scores (GIRA)
in clinical practice, the eMERGE IV administrative supplement proposal leverages our expertise
from leading the All of Us Research Program retention campaign, and the MGB Decentralized
Clinical Trials Program, we are proposing to deploy novel communication methods and research
navigator workflows to enhance recruitment and retention in eMERGE. Specific aims: Aim 1:
Enhance equity in recruitment and return of GIRA results by employing novel communications
methods to diverse participants at baseline and at follow-up survey time points. We will develop
culturally sensitive new recruitment materials for Hispanic/Latino and Black participants, utilizing
plain language and graphics to explain study steps more clearly, explain that survey completion
is required to receive results and the importance of fully engaging at all points in this longitudinal
study. Our Spanish-speaking team will translate existing study materials to improve
comprehension by Hispanic/Latino participants. New and existing materials will be shared
throughout the eMERGE network to reduce survey data missingness and improve health equity.
Aim 2: Deploy a research navigator model with a diverse study team, to assign a navigator to
each participant, to guide and assist participants at each step in eMERGE from consent, survey
completion, sample collection, GIRA return, through collection of follow-up surveys. We will use
omni-channel communications based on participant choice (phone, text, email) and track
successful methods to inform the eMERGE network whether the navigator model with
personalized communication methods can be used at other sites. For participants who do not
complete surveys, we will perform chart reviews to collect key variables needed for GIRA to
increase the rate of equitable data collection and return of GIRA reports with minimal missing
data on demographic, clinical, and family history risk factors. Given the striking disparities in
data missingness the early phase of eMERGE IV by race and ethnicity, and the decision by the
network not to send samples for PRS analysis unless baseline survey data is provided by
participants, the study is at risk for introducing disparities in the return of results, thus biasing its
conclusions. Achieving health equity requires extra effort and focused methods to enhance
education, encourage full participation at each step of the program, provide assistance at an
individual level and gather data from available sources such as EHRs if we aim to eliminate
disparities in health and health care. Lessons learned in this administrative supplement will be
shared across the eMERGE network to enhance health equity of the entire study.

Public health relevance
Narrative. Lower response rates to baseline surveys among participants who have been historically under-represented in biomedical research (UBR) threaten equity in returning genetic results in eMERGE IV. We propose to address this challenge by developing novel communications methods and tools to be deployed across eMERGE and utilizing a research navigator model to guide UBR participants through all steps of the program. Our goal is to improve survey completion rates for baseline and follow-up questionnaires, and supplement survey data with chart reviews of electronic health records (EHR), to ensure health equity, and that the benefits of receiving GIRA reports are experienced by all participants